Development of Investigators Supporting Community Outreach and Value of Engagement in health disparities Research (DISCOVER)

Modified Abstract Section

ABSTRACT

The Administrative Core (AC) of the DISCOVER Center of Excellence embodies core principles essential for achieving its mission to promote health and research on differential health outcomes – scientific leadership, strategic direction, collaboration and synergy, and career development. Serving as the central hub that coordinates the activities of the various Cores within the center, the AC undertakes several critical functions. The AC exercises administrative oversight over all aspects of DISCOVER by providing strategic direction across the center, ensuring efficient coordination and seamless interaction between the Cores, and working to maximize their collective impact. The AC oversees information exchange between Cores, stakeholders, and community members through a well-structured Communication Plan, involving a user-friendly website, newsletters, and regular updates. By fostering collaboration and synergistic interactions, the AC ensures seamless cooperation among investigators and mentors, creating a supportive environment for all. The AC aims to: Aim 1. Design and implement an effective governance structure to manage and coordinate the work across DISCOVER Cores. We will: a) Organize DISCOVER’s External, Internal, and Community Advisory Boards, the Executive Committee, and Core Leadership structure and meeting schedules; b) implement internal and external communication strategies to promote collaboration and efficiency across the work of each core; and c) oversee management and tracking of DISCOVER reporting. Aim 2. Administer pilot funding and track and evaluate research and professional development outcomes among DISCOVER investigators. We will: a) provide pilot funding and oversee administrative aspects of the call for proposals and review process, b) provide oversight of mentor lists and completion of mentor training, and c) track and evaluate DISCOVER investigators’ progress on pilot research, scientific productivity, and professional development outcomes. Aim 3. Communicate DISCOVER training activities and investigators’ research progress and career accomplishments. We will: a) promote DISCOVER training, career development, and pilot funding opportunities to reach a broad group of early career investigators across GUMC, and b) showcase investigators’ scientific and career accomplishments through an Annual Research Retreat and communication with the research community.